The role of notch modulation in spatially defined hematopoiesis

Abstract
Hematopoietic stem cell (HSC) transplantation is a potent therapeutic strategy for the treatment of many blood
disorders. Therefore, the development of methods for deriving large quantities of HSCs is a major focus in
regenerative medicine. Unlike HSCs, human induced pluripotent stem cells (hiPSCs) can be grown indefinitely.
Despite hiPSCs being an extremely scalable source, HSCs derived from hiPSCs using current protocols are
largely devoid of long-term blood reconstitution potential. These shortcomings are suggestive of knowledge gaps
surrounding HSC biology. In the Camargo lab we leveraged our in-vivo barcoding mouse model to show
definitively that HSCs arise from both intraembryonic (aorta) and extraembryonic (umbilical and vitelline arteries)
sites during native hematopoiesis, and that these sites play differential roles in blood production. Our findings
suggest for the first time that umbilical and vitelline (UV) artery HSCs are more short-lived than aortic HSCs, and
that the UV artery engages potently in embryonic lymphopoiesis. By performing single cell RNA-seq on murine
blood producing endothelial cells, I observed differential NOTCH signaling strength and the presence of NOTCH
inhibitors GPR183 and DLK1 in the aorta and UV arteries respectively. While it is vastly appreciated that a
transient reduction in NOTCH signaling strength is required for hematopoiesis to occur, no study has detailed
differential mechanisms of NOTCH inhibition at spatially distinct HSC-producing sites. Cross-referencing this
site-specific data with scRNA-seq on a commonly used hiPSC hematopoietic differentiation protocol, I identified
for the first time the exclusive prevalence of the UV-like hemogenic endothelium in vitro. To develop methods of
producing long-lived HSCs with adult-like lymphoid potential, we plan to study the Notch pathway as a regulator
of site-specific hematopoiesis and modulate NOTCH signaling strength to produce more aortic-like hemogenic
endothelium from hiPSCs. From this preliminary data, we hypothesize that differential NOTCH signaling strength
is crucial for producing distinct hematopoietic programs in the UV arteries and the aorta. To test this central
hypothesis, we plan to pursue the following specific aims: (1) characterize the role of GPR183 in aortic
hematopoiesis through murine loss of function studies, (2) describe the role of DLK1 in UV hematopoiesis by
murine loss of function, and (3) determine the function of DLK1 in controlling the hiPSC spatial hematopoietic
program. From these experiments we expect to elucidate the role of these NOTCH inhibitors in spatially defined
hematopoiesis. By leveraging our site-specific scRNA-seq dataset, we are uniquely positioned to produce
methods of deriving aortic-like blood cells. These novel blood populations have the potential to revolutionize the
therapeutics landscape.

Public health relevance
Project Narrative Human induced pluripotent stem cell (hiPSC) derived hematopoietic stem cells (HSCs) offer a scalable source of HSCs for the treatment of blood disorders; however, current protocols deriving HSCs from hiPSCs are largely devoid of long-term reconstitution potential. From my studies characterizing spatially defined hematopoiesis in HSC-producing arteries I identified distinct NOTCH modulators which I believe control site-specific differences in hematopoiesis and hinder the production of HSCs with long-term reconstitution potential from hiPSCs. I aim to functionally characterize these spatially distinct NOTCH modulators in restricting cell fate both in vivo and in vitro with goals of discovering methods for enhancing long-term HSC production from hiPSC.